INRSA Training Grant in Gastroenterology

? DESCRIPTION (provided by applicant): Training creative and productive academicians is a critical mission of gastroenterology programs. Emerging discoveries in related fields ranging from human genetics to molecular and cellular biology, microbiology and epidemiology have had major impacts on the understanding of pathophysiology of gastrointestinal diseases. The understudied potential of the microbiome is a major new area of investigation. The UCSF Division of Gastroenterology has been a leader in gastrointestinal research for over 45 years. In addition, allied Divisions and Departments at UCSF augment the training program by providing complementary and synergistic training experiences. During the past funding cycle, we have significantly enhanced our training faculty and revamped our selection and training procedures to optimize the success of our trainees. The enhanced pool of applicants and trainees in our program, greater success of trainees in the program, and markedly improved outcomes of our trainees attests to the success of our efforts. In this application, we propose to continue our training of innovative and creative academic investigators in gastroenterology.

Public health relevance
PUBLIC HEALTH RELEVANCE This application is for support of four training positions in an established program in digestive diseases that has been funded since 1975 at the Division of Gastroenterology, University of California, San Francisco. The Program's goal is preparing trainees for careers in academic luminal gastroenterology, and its track record in this regard is outstanding, with numerous graduates of the program now in leadership positions. The training environment is broadly interdisciplinary, reflecting the synergistic relationships of the Division of Gastroenterology wit the IBD Center, the Immunology Program, the Cancer Center, the Institute of Molecular Medicine, and the graduate programs for Biomedical Sciences and Biological Sciences. During the past funding cycle, significant enhancements to our trainee pool and our mentoring faculty have led to markedly improved productivity and outcomes for our trainees. These talented individuals are well poised to capitalize on the exciting state of GI related research, with its transformative and translational potential